Outreach Core

ABSTRACT -­ Outreach Core The Outreach Core of the M2CH-­CSBC (Measuring, Modeling and Controlling Heterogeneity-­Cancer Systems Biology Consortium) Center will deliver educational materials, experimental and computational tools and data to the CSB Consortium, the CSBC/PS-­ON Coordinating Center and the broader scientific community. The Outreach Core with logistical, support from the Administrative Core, will: (1) deliver interdisciplinary education and cross-­ training on multiscale measurement instrumentation, and the generation, use, and analysis of 4D images impacting cancer and therapeutic response;? (2) provide access to the bioimaging and genomic data using a custom portal for access, visualization, and interactive analysis based on OMERO (Open Microscopy Environment image database) and Sage Synapse;? and (3) conduct DREAM crowd-­sourcing activities to seek analytical solutions to question in spatial systems biomedicine. Aim 1 will deliver introductory and advanced topic workshops on unique imaging platforms accessible to the CSBC and general public. Hands-­on training workshops utilizing multiscale imaging instrumentation, optimized techniques and workflows, and computational analytics also will be provided as part of a biannual multiscale imaging symposium. This symposium designed to foster collaboration among biomedical scientists, bioengineers, mathematicians, and computational biologists, at all stages of their careers, will support the interdisciplinary and trans-­consortium interactions that are fundamental to achieving the CSBC research goals. Cross-­network personnel exchanges for in-­depth training are offered. Aim 2 will build on an existing collaboration with Sage Bionetworks and leverage work conducted under the auspices of the NIH Library of Integrated Network-­Based Cellular Signatures (LINCS) Common Fund and Big Data to Knowledge (B2DK) Programs to make computational infrastructure for accessing, visualizing, and quantitatively analyzing bioimaging data available to the CSBC and wider research community. This will include: (a) access to M2CH-­CSBC image and single cell sequencing data from our customized workflow platforms, (b) development of a Sage Synapse based M2CH-­CSBC public data portal that will leverage our metadata management, provenance tracking, data versioning, governance and access control analysis and visualization, and (c) powerful image analytics and integration of imaging and single cell sequencing data through analytical and visualization tools optimized by OHSU Center for Spatial Systems Biomedicine (OCSSB) collaborators. Aim 3 will work with Sage Bionetworks to develop crowd-­sourcing solutions to ?omic/image data visualization, identification of networks that control cell phenotypes and response to therapy and development of therapeutic strategies to control epigenomic plasticity and response to microenvironmental signals.